Unlocking the Potential of the GSC-Associated lncRNA GIHCG as a Therapeutic Target in Glioblastoma

PROJECT SUMMARY
Glioblastoma (GBM), the most aggressive and prevalent brain tumor, is marked by a grim prognosis despite
standard treatments like surgery, chemotherapy, and radiotherapy. The limited success of these treatments is
largely due to GBM's high recurrence and resistance, underscoring the urgent need for innovative treatment
strategies. Numerous studies have indicated that glioblastoma stem cells (GSCs) are key drivers of tumor
growth, therapy resistance, and relapse. Recent advancements in sequencing technologies revealed a vast
landscape of long noncoding RNAs (lncRNAs), a class of RNAs with significant regulatory potential in cancer
biology, that may serve as promising therapeutic targets. Here, we propose to characterize a newly identified
GSC-associated lncRNA GIHCG, which is essential for GSC survival. Our preliminary data revealed that GIHCG-
specific siRNA-mediated knockdown reduced GSC proliferation, migration, and self-renewal capacity. Notably,
high levels of GIHCG expression correlate with poor patient outcomes in GBM, suggesting its oncogenic
potential. Based on these findings, we hypothesize that GSC-associated oncogenic lncRNA GIHCG plays a
critical role in GBM initiation and progression and could function as a potential biomarker and/or therapeutic
target in GBM. To achieve this, we propose three specific aims: First, we will generate a GIHCG knockout in
GSCs using a dual-guide CRISPR/Cas9 approach to delineate the molecular pathways involved in GSC
proliferation, migration, and stemness (Aim 1). Second, we will assess the crucial role of GIHCG in GBM
progression using preclinical ex vivo cerebral organoid and in vivo xenograft mouse models (Aim 2). Finally, we
will investigate the functional interactions of GIHCG with chromatin and proteins using chromatin isolation by
RNA purification (ChIRP) and ChIRP- mass spectrometry (ChIRP-MS) (Aim 3). In summary, this study aims to
provide a comprehensive molecular characterization of the GSC-specific lncRNA GIHCG and elucidate its role
in GBM progression, with the goal of advancing RNA-based therapy for high-grade brain cancers.

Public health relevance
PROJECT NARRATIVE This study aims to determine the role of the long non-coding RNA, GIHCG, associated with glioblastoma stem cells, in promoting the initiation and progression of glioblastoma. The findings are expected to offer valuable insights that could lead to new treatment strategies for this aggressive form of brain cancer.